NIAAA ALCOHOL EPIDEMIOLOGIC DATA SYSTEM (AEDS)

The Alcohol Epidemiologic Data System (AEDS) is a mechanism through which the National Institute on Alcohol Abuse and Alcoholism (NIAAA), National Institutes of Health (NIH), disseminates the latest findings about the effects of alcohol on human health, to other researchers, health professionals, and the public.